(PQ1) Progenitor cell malfunction, mutations and changes in microenvironment: A dynamic risk spectrum for cancer evolution

Project Summary/Abstract
In this proposal we will address the provocative question (PQ1): “For tumors that arise from a
premalignant field, what properties of cells in this field can be used to design strategies to inhibit the
development of future tumors?
We will focus on squamous cell lung cancer (SCC), a common cause of cancer mortality and a
neoplasm for which there is considerable evidence supporting an origin from a premalignant field. We propose
to answer this question through a comprehensive strategy that focuses on three critical elements of the
premalignant field for SCC of the lung: epithelial progenitor cell function, which is required for repair and
maintenance of a healthy epithelium; genomic alterations in premalignant dysplasias; and the composition
and function of the microenvironment. We hypothesize that “Evolution of lung cancer from a field of
premalignant dysplasia is driven both by intrinsic changes in epithelial progenitor cells as well as
changes that occur in the field microenvironment. Thus, therapy could be targeted to rescue functions
of epithelial progenitor cells and/or to restore the microenvironment.” We propose three aims to address
this hypothesis. Aim 1. Mechanisms of progenitor malfunction to identify new targets for
chemoprevention: We will determine whether epithelial progenitor malfunction in terms of self-renewal and
multipotentiality varies across a dysplasia spectrum. We will also assess whether progenitor response to the
chemopreventive agent iloprost differs across this dysplasia spectrum. RNA sequencing will explore
determinants of progenitor dysfunction and response to iloprost, potentially identifying novel interventions and
predictive biomarkers. Aim 2. Detecting novel genomic changes to identify new targets for
chemoprevention: We will assess whether the genetic and epigenetic profile of dysplasia varies across the
above dysplasia spectrum. Brushings collected from the same dysplasia spectrum will be used to identify
mutations, epigenetic alterations and transcriptomal changes; all compared to the tumor in those subjects with
SCC. Targetable mutations and pathways will be identified. Aim 3. Changes in composition and function of
microenvironment to identify new targets for chemoprevention: We will assess whether the
microenvironment varies across the above dysplasia spectrum. Mass cytometry will be used to characterize
cells that constitute the field microenvironment. We will also explore cellular heterogeneity in the field in a
subset of dysplasias with known history of persistence/progression or regression using single cell
transcriptomic profiling of flow-sorted epithelial and non-epithelial cells. Identification of intervention targets,
such as immune checkpoints, inflammation and angiogenesis will be our goal. We anticipate that our
integrative approach will lead to new strategies to prevent the evolution of premalignancy to invasive SCC.

Public health relevance
Public Health Relevance Lung cancer is the leading cause of cancer mortality in the US and the world. Smoking cessation or avoidance is the best preventive action, but former smokers remain at risk for lung cancer for many years after cessation. Thus, additional interventions are needed to prevent the development of lung cancer, particularly in former smokers. There is strong evidence that lung cancer arises from a premalignant field in which the epithelium evolves into cancer. This proposal focuses on squamous cell lung cancer (SCC), which is the second leading histologic type in the US, as the premalignant field can be most readily accessed for study. We propose a comprehensive analysis that includes epithelial progenitor cells, premalignant epithelium and the subepithelial microenvironment, all of which contribute to carcinogenesis. The information coming from this work will inform the development of new chemoprevention strategies to target premalignancy so as to prevent the development of lung cancer.